Developmental regulation of lens gene expression

ABSTRACT
The long-term goal of this research program is to uncover the transcriptional and posttranscriptional
mechanisms coordinating the regulation of tissue-specific gene expression during mammalian embryonic
lens development and differentiation. Despite the simple composition of the lens that contains only two
mature cell types, the full range and spectrum of mechanisms and pathways governing lens gene
expression remain to be identified. A hallmark feature of lens development and cellular differentiation is
the temporally and spatially regulated expression of a- and b-/g-crystallins required for lens structure,
homeostasis and transparency. This application seeks to identify novel cis-acting DNA regulatory sites
and novel RNA-binding proteins (RBPs) that regulate the expression of mammalian crystallins in vivo
during lens differentiation. We have now linked the expression of the bB3-crystallin gene in the lens with in
vivo binding of transcription factor Pax6 to its “open” promoter chromatin domain in lens enabling
prediction of novel cis-acting sites and transcription factors and their posttranslational modifications
(PTMs) that spatially and temporally control its expression. We have also discovered transient nuclear
accumulation of spliced Crybb3 mRNAs in early lens fiber cell nuclei along with multiple spatially and
temporally regulated RBPs that likely regulate bB3- and other crystallin mRNAs transport, stability,
translation and decay. These general mechanisms control expression of other lens-specific genes making
their discovery an essential first step towards understanding both transcriptional and posttranscriptional
regulatory mechanisms underlying lens differentiation. To test our predictions, Aim 1 is designed to
uncover the lens-specific cis-regulatory grammar regulating the mouse Crybb3 as a model crystallin. Aim
2 is designed to examine posttranscriptional regulation of lens gene expression by identifying novel RBPs
and their sites in crystallin mRNAs particularly within their 3’-UTRs, determining function of identified
differentiation-regulated RBPs, and employing a state-of-art MS2-MCP system to in vivo track individual
crystallin mRNAs from their birth in the nucleus throughout their nuclear export and localization in the vast
space of lens fiber cells at single molecule resolution. These results will reveal those mechanisms linking
a-, b/g-crystallin mRNA regulation, identify novel and diverse RBPs that interact with crystallin mRNAs,
establish molecular mechanisms of Crybb3 transcription, and provide new insights into the 3D-distribution
of individual crystallin mRNAs in lens fiber cells at specific stages of lens cell differentiation. Together,
these studies will generate transformative insights into the molecular and cellular mechanisms required for
mammalian lens morphogenesis, transparency and refraction and provide a basis for comprehensive
understanding of gene expression in more complex tissues in and outside of the eye.

Public health relevance
PROJECT NARRATIVE Lens cataract originates from disrupted lens microarchitecture and is a major cause of worldwide blindness. The majority of cataracts are caused by mutations in all crystallin genes, DNA-binding transcription factors (e.g. PAX6, MAF and HSF4), RNA-binding proteins (TDRD7 and Rbm24), and through mutations in 5’-UTRs of lens expressed genes (ferritin light chain FTL and solute transporter SLC16A12). Novel non-coding mutations in crystallin and other loci encoding abundant lens proteins remain poorly understood and this proposal will add insights into the function of non-coding cis-acting regulatory regions that will facilitate interpretation of human GWAS studies.